CORE--METHODOLOGY

Description: (Adapted from applicant's description) The Methodology Core has been designed to provide support in three broadly defined areas: Data Acquisition, Data Management and Communications, and Data Analysis. The specific objectives of the Methodology Core are to (a) facilitate acquisition of data; (b) develop tools and procedures for ensuring and monitoring the accuracy and confidentiality of all collected data; (c) develop databases for all behavioral and cognitive data; (d) facilitate communication and sharing of data among investigators through state-of-the-art computer networking; and (e) provide statistical support to investigators in the evaluation of hypotheses.